Role of E-cadherin in modulating airway epithelial function and parenchymal remodeling

PROJECT SUMMARY
Chronic Obstructive Pulmonary Disease (COPD) is the 4th leading cause of death in the US with emphysema
progression and lung function decline with evidence of poor mucociliary clearance and airway epithelial changes
as well as alveolar destruction. We have found that in COPD there is a significant decrease in adherens junction
protein E-cadherin, which is a primary component dictating cell-cell adhesion a finding which has been verified by
several investigators and in large cohort studied. In this proposal, we will decipher the effects of E-cadherin
regulation in promoting changes in epithelial function in the airways and parenchymal modeling and determine if
increased E-cadherin protects the epithelia and the lungs from cigarette smoke (CS). We propose that
decreased lung epithelial E-cadherin leads to loss of polarity of the epithelial cell, disrupts the epithelial barrier f
and decreases ciliary beat frequency to promote airway dysfunction. Furthermore, we propose that loss of E-
cadherin promotes parenchymal remodeling. We will dissect two specific mechanisms which could contribute to
decreased protein levels. In Aim 1, we will determine if E-cadherin knockdown in cells, ex vivo trachea and
mouse models lead to epithelial dysfunction and altered tissue integrity indicating that loss of E-cadherin with
chronic smoke exposure or in patients with COPD serves a causal role in the development of COPD.
Specifically, we will determine if lung E-cadherin loss alters epithelial polarity and decreases ciliary beat
frequency, mucociliary clearance, and maintenance of the air surface liquid. In addition, we will determine if E-
cadherin loss promotes parenchymal remodeling and inflammation using mouse models. In Aim 2, we will
study novel mechanisms by which E-cadherin is decreased in the context of CS exposure and COPD.
Specifically, we will study if epigenetic regulation of the promoter contributes to decrease in mRNA and protein
abundance. Our data shows that CDH1 is methylated in an area rich with regulatory elements, so we will study
these elements to determine what is altered with CS exposure. In addition, we have identified a post-
translational modification which correlates with E-cadherin function in population studies. Specifically, we will
determine if terminal fucosylation of E-cadherin increases its adhesion strength to enhance function. We have
identified a specific identified polymorphism or a haplotype that is associated with functional changes and will
genetically engineer this into a lung cell line to determine if these affect E-cadherin based cell-cell adhesion and
function. In addition, we will determine if mice lacking this fucosylation have increased susceptibility to CS
exposure. In Aim 3, we will perform proof of concept studies to determine if upregulation of E-cadherin serves as
a therapeutic strategy in primary human cells and mouse models. In addition, we will determine if
manipulating the pathways identified in Aim 2 upregulate E-cadherin and improve function in the context of CS
exposure.

Public health relevance
PROJECT NARRATIVE Chronic Obstructive Pulmonary Disease (COPD) is the fourth leading cause of death in the United States with significant damage to the lung epithelium. In this proposal, we dissect the role of E-cadherin on airway epithelial function and parenchymal remodeling to determine if loss of E-cadherin is causal to disease while gain in function is protective from damage from cigarette smoke. We have identified two potential regulatory mechanisms including promoter methylation and post-translational fucosylation that may influence E-cadherin abundance and bond strength and could serve as modifiable to upregulate E-cadherin levels.